Commensal fungi promote wound repair by modulating host metabolites

Abstract
The intestinal epithelium acts as a physical barrier to separate the luminal contents from the underlying tissue
compartment of the organ. Typically, any damage caused by medications or environmental toxins is promptly
repaired to maintain homeostasis. However, in chronic inflammatory conditions such as inflammatory bowel
diseases (IBD), ability to heal wounds is dysregulated perpetuating chronic inflammation. Healthy endogenous
microbiota is being increasingly recognized to promote repair, yet the specific mechanisms by which microbes
guide repair remains elusive. Moreover, majority of the studies have focussed on bacteria, how nonbacterial
members such as fungi modulate wound repair remains unknown. Using murine models of injury and repair and
human isolates of fungi, we discovered that endogenous fungi are critical for crypt regeneration post injury.
Importantly, the repair promoting effects were specific to the fungal strains that are depleted in IBD. Our
preliminary data suggests that endogenous fungi engage epithelial cells to induce Palmitoylethanolamide (PEA),
a lipid metabolite, which in turn inhibits inflammatory activation of fibroblasts to promote wound repair. Here we
will use conditional knockout mice, single cell RNA sequencing, primary epithelial and fibroblast cultures, and
metabolomics to investigate how endogenous fungi alter epithelial transcriptome to induce PEA (Aim 1) and the
specific mechanisms by which PEA inhibits inflammatory activation of fibroblasts to promote repair. Successful
completion of these aims will give a mechanistic understanding of a previously unappreciated role of endogenous
fungi in modulating epithelial cells and fibroblasts to enhance intestinal wound repair. Additionally, it will uncover
novel targets for stimulating crypt regeneration in inflammatory conditions of the gastrointestinal tract.

Public health relevance
Project Narrative The mechanisms underlying poor wound repair in chronic inflammatory conditions of the intestinal tract such as inflammatory bowel diseases remain poorly understood; evidence supporting this assertion is that we have no directed therapy in human disease to specifically promote repair. We discovered that select commensal fungi induce host lipid metabolites which in turn inhibit inflammatory activation of fibroblasts to promote crypt regeneration. The findings from this study will reveal novel mechanisms of wound repair and provide critical opportunity to identify therapeutic targets for promoting repair in chronic intestinal diseases.